Atrial and blood JNK in Postoperative AF

Atrial fibrillation (AF) is the most common arrhythmia and has a high risk of mortality and morbidities. Among the
general AF population, new-onset postoperative atrial fibrillation (POAF) is the most common complication after open-
heart surgery, which significantly increased mortality and amplifies hospital and patient costs. The mechanisms
underlying POAF are unclear, thus effective prediction and/or prevention remain unavailable. This proposal aims to
fill this knowledge gap by identifying stress-response kinase JNK as a novel POAF biomarker for surgery patients
and exploring the translational potential of local JNK inhibition in atria as a novel anti-POAF therapeutic
approach. Predisposing factors for POAF include advanced age, binge alcohol, as well as intraoperative and
postoperative atrial injury and/or ischemia. One common element among these factors is tremendously increased
cellular stress, which is known to activate the c-Jun N-terminal kinases (JNKs), an important stress-response kinase.
We recently discovered and reported a previously unrecognized causal link between cardiac JNK activation and
abnormal cell-cell communication (via gap junction channels) as well as abnormal Ca triggered activities which
enhance AF propensity. Our intriguing preliminary findings suggest that atrial JNK activation is well correlated to
POAF incidence in patients within 10 days of coronary artery bypass graft (CABG) surgery, indicating POAF likely
involves JNK activation and possible JNK-driven atrial arrhythmogenesis. Intriguingly, our preliminary results show
for the first time that JNK is present in blood. And JNK activation in the heart increases blood JNK. Accordingly, the
concordant atrial JNK activation and rise in plasma JNK levels correlates nicely to the increased incidence of AF.
Next, we found that most of the plasma JNKs are carried by microparticles (MPs) circulating in the blood. Our pilot
data further suggest that heart cells shed JNK-microparticles (JNK-MPs). All these intriguing preliminary results
combined with our previous findings point to a unique heart-blood JNK relationship that links to AF pathogenesis.
Here, we will use a series of cutting-edge biochemical assays and electrophysiological techniques on surgically
removed intact atrial tissue, isolated atrial myocytes and blood samples from CABG patients and human donor hearts
as well as animal models recapitulating AF risk factors (aging & binge alcohol). Our Specific Aims are: 1) Establish
the electrophysiology & biochemistry profiles of JNK, pro-inflammatory cytokins, and arrhythmic substrates in
atrial tissue/blood of CABG patients and their correlation to POAF incidence; 2) Prove activated JNK in the blood
is a biomarker of POAF risk and test a potential AF therapeutic atrial painting gene transfer intervention in aged
rabbits. Establishing the atrial/blood JNK as a possible biomarker of POAF risk is entirely novel here. Clinical
accessibility for both atrial tissue and blood samples and POAF events make CABG patients an ideal population for
studying the JNK-AF link in humans. Developing an atrial painting gene transfer intervention that could be applied to
high POAF risk patients during surgery is innovative. The unique combination of cardiac research expertise and
novel electrophysiology/biochemistry techniques makes this proposal technically & experimentally innovative.

Public health relevance
New onset postoperative atrial fibrillation (POAF) is the most common complication after cardiac surgery and substantially affects patient outcomes from the surgery. Our study aims to identify/test the stress-response kinase JNK as a novel POAF biomarker and/or potential anti-POAF therapeutic target. The results from this proposal will form a strong foundation toward achieving our long-term goal of developing novel therapies to treat and prevent AF.